CENTRAL COORDINATION OF NCTN AUDITING ACTIVITIES

Establish a tier-system approach based on accrual for determining the frequency of conducting audits to Adult NCTN and NCORP participating sites in the U.S. and its territories. Establish and implement as part of the NCTN Centralized Functions, a system for coordinating and conducting single site audits across multiple Adult Network groups for high enrolling and moderately high enrolling participating sites in the NCTN/NCORP in the U.S. and its territories.